FLUORESCENCE STUDY OF PLASMA MEMBRANE CA2+ ATPASES

Fluorescence quenching of multitryptophan protein PM ATPase by general anesthetics such as isoflurane or barbiturate has been studied. The measurements include also other quenchers (alcohols). The quenching data provide the information of permitivity of macromolecules to the quenchers. Preliminary data show that quenching has diffusional character and lifetime measurements are necessary to correctly interpret the results. The time-resolved lifetime measurements are expected to help in resolution of origin of fluorescence to answer the question are only exposed tryptophan being quenched.